Molecular Genetics of Visual Circuit Assembly in the Developing Superior Colliculus

My long-term goal is to understand how neural circuits underlying specific brain functions are formed, modified
by experience, and altered in neurological conditions. The goal of this proposal is to examine mechanisms that
regulate formation of the long-range neuronal connections between the superior colliculus (SC) and specific
subcortical brain areas. We chose to focus on the connections between superficial layer of SC (sSC) and the
thalamus. The SC is a midbrain center that plays an important role in sensory and motor processing. The sSC
receives visual inputs from the retina and cortex, and sSC-thalamic connections are known to mediate
defensive responses to threating visual stimuli. As most of traditional studies have investigated organization of
sensory inputs to sSC, little is known about mechanisms regulating development of sSC output pathways.
Moreover, no study has described developmental regulation of sSC-thalamic circuits underlying visually-driven
behavioral responses. In a screen for the markers labeling subsets of sSC neurons, we have identified several
genes that are likely to control development of sSC neurons. Now, we propose to investigate the role of those
molecules in sSC output circuit assembly. We have already demonstrated that a transcriptional factor, retinoid-related orphan receptor β (Rorβ), regulates sSC neuronal projections to specific thalamic nuclei. Here, we plan
to examine downstream mechanisms of Rorβ-dependent regulation by gain- and loss-of-function approaches.
We will also investigate the role of another transcription factor, Brn3b, in the development of distinct sSC
circuits and identify the downstream effectors of Brn3b. Given that sSC neurons, confined to specific
sublayers, selectively project axons to distinct thalamic nuclei, and that Brn3b and Rorβ are expressed in
different sublayers of sSC, we hypothesize that Brn3b regulates axonal projections via Rorβ-independent
mechanisms. Manipulations of Rorβ and Brn3b expression produce different patterns of altered axonal
projections to the thalamic nucleus, known to govern visual-cue triggered behaviors. Based on these findings,
we will test if Rorβ- and Brn3b-dependent mechanisms of circuit assembly are required for appropriate
behavioral responses to visual threat. The success of the proposed project will improve our understanding of
the molecular basis for establishing the long-range connections between sSC and thalamic areas. It will also
provide novel mechanistic insights into developmental assmebly of subcortical visual circuits regulating
responses to the threatening stimuli.

Public health relevance
This proposal aims to define molecular mechanisms regulating formation of specific subcortical circuits that potentially mediate visually-driven defensive behaviors. Proper neuronal connectivity within specific circuits underlies appropriate behavioral responses, and defective developmental wiring often disrupts such behaviors in a variety of neurological disorders. The success of the proposed project should provide new insights into assembly of the neural circuits conveying reactions to the visual threat and help us understand both function and dysfunction of fear-related brain circuitry.